Identifying Potential Therapeutic Targets for Abusive Head Trauma

PROJECT SUMMARY
The pathophysiology of hemispheric hypodensity is unknown. It is a pattern of brain damage only occurring in
young children, often resulting from abuse, where the majority of the hemisphere underlying the subdural
hematoma appears hypodense on computed tomography spanning multiple vascular territories. When the
subdural hematoma is over one hemisphere, the damage is predominantly unilateral. Recently, we
successfully induced unilateral hemispheric hypodensity in piglets developmentally similar to human toddlers
by re-creating the clinical characteristics of this injury: mechanical trauma, midline shift, subdural hematoma,
seizures, apnea, and hypoventilation. This model results in an age-dependent neurologic impairment,
metabolic acidosis, and unilateral hypoxic-ischemic-type injury encompassing most of the cortex underlying the
subdural hematoma. The pattern of damage, degree of vasogenic edema, and upregulation of matrix
metalloproteinases are age-dependent. The percentage of hemispheric damage is positively correlated with
hemorrhage area and seizure duration. Our long-term goal is to understand the age- and injury-specific
pathophysiology to develop therapies that halt or inhibit the progression of tissue damage after abusive head
trauma. The overall objective in this application is to determine the contribution of seizures and hemorrhage in
the development of the damage and if the cascades of injury can be aborted. Our central hypothesis is that the
large forces generated from abuse causes extensive tissue damage that is primarily driven by an interplay
between focal seizures and hemorrhage and that the resultant damage cascades can be arrested with anti-
epileptic drugs. The rationale is that by understanding the pathophysiology and determining if the tissue is
salvageable, then therapeutics that potentially halt the damage can be tested. We will test our central
hypothesis with two specific aims:1.) Determine the contribution of seizures and hemorrhage to the
development of unilateral hemispheric hypodensity; and 2.) Determine if stopping seizures at a time when
children present to the emergency department prevents the extensive damage. Our contribution is the first
model of hemispheric hypodensity that replicates the potentially synergistic multifactorial injury cascades within
comparable developmental stages and brain morphology of human infants and toddlers where the
pathophysiology and contribution of seizures can be determined. This approach is innovative as it departs from
the status quo of using a single injury to induce “severe traumatic brain injury”; instead, we study the
synergistic interplay of multiple injuries and insults and manage 30 hours of critical care using standard
pediatric critical care protocols with clinically relevant outcomes. The proposed contribution is significant
because age-specific therapies that abort the cascades of the pathophysiology of abusive head trauma might
reduce the severity of neural damage and reduce the number of infants that die or are permanently disabled.

Public health relevance
PROJECT NARRATIVE It is estimated that the majority of severe head injuries in children under age 2 are due to abuse. Hemispheric hypodensity is a striking pattern of brain damage often resulting from inflicted trauma where tissue damage evolves over hours or days and for which there is no treatment. Understanding the pathophysiology of this severe injury will identify potential therapeutic targets that may result in therapies that reduce the burden of disability and mortality for victims of abusive head trauma.